Role of gut microbiome dysbiosis and sustained inflammation in osteoarthritis

PROJECT SUMMARY
Title: Role of gut microbiome dysbiosis and sustained inflammation in osteoarthritis
This application seeks support for a specialty board certified veterinary surgeon embarking on an independent
career as a translational clinical scientist. The applicant proposes a multi-disciplinary approach to study the
role of the gut microbiome and immunome in osteoarthritis (OA) progression, with mentorship from leading
experts in skeletal homeostasis and disease, osteoarthritis, microbiology, immunology, and pathology at the
University of Colorado Anschutz Medical Campus (UCAnschutz) and Colorado State University (CSU). The
applicant would work under the mentorship of: Michael Zuscik, PhD, in the Department of Orthopedics at
University of Colorado Anschutz Medical Campus and Kelly Santangelo, DVM, PhD, and Steven Dow, DVM,
PhD, in the Departments of Microbiology, Immunology, Pathology and Clinical Sciences at Colorado State
University. The applicant’s proposal would leverage her research background in osteoarthritis and previous
experience as a veterinary surgeon with clinical access to equine orthopedic patients to address the overall
hypothesis that the gastrointestinal tract and joint microbiome in OA have expanded populations of specific
pro-inflammatory bacterial populations that sustain local synovial inflammation in progressive OA using the
relevant large animal (equine) model to address questions that would not be possible in human patients.
Specifically, this proposal aims to 1) identify shared populations of pro-inflammatory bacteria in the gut and
joints of horses with naturally occurring OA and systemic inflammation, 2) interrogate the impact of pro-
inflammatory bacteria and their secreted products on activation of relevant joint immune cells, and 3)
determine whether pathogenic bacteria are preferentially recognized by antibodies in synovial fluid and blood
from horses with OA. The career development plan and training program described will specifically allow the
applicant to develop depth of knowledge 1) in the role of the microbiome and bacterial metabolites in
orthopedic pathology acquiring advanced expertise in next generation sequencing techniques, 2) develop skills
in immunological methods including fluorescence activated cell sorting, immunocytochemistry, and
immunoassay readouts, and 3) refine musculoskeletal pathology techniques. The candidate is a tenure-track
early-career assistant professor with support from the Department of Clinical Sciences to remain in at least a
75% research commitment with 25% service/teaching commitment for the duration of the grant term if
awarded. Further, she has her own dedicated laboratory space in the Translational Medicine Institute in the
College of Veterinary and Biomedical Sciences at CSU and is supported by a transdisciplinary team of
investigators with experience in microbiology, immunology and pathology. These studies aim to fill a critical
gap in our understanding of how the dysbiotic gut microbiome and inflammasome drive progressive OA.

Public health relevance
PROJECT NARRATIVE Title: Role of gut microbiome dysbiosis and sustained inflammation in osteoarthritis Osteoarthritis (OA) is a debilitating condition impacting 33 million people in the US, which poses a huge economic burden due to reduced productivity and health-care costs. Dysregulation of the gut microbiome has been recently established to be an important driver of both post-traumatic and obesity-associated OA, mediated through sustained gut inflammation. These studies are intended to fill a critical gap in our understanding of the mechanistic underpinnings of microbiome-immune interactions in OA progression and their impact on overall joint immunity and health.